Identifying determinants of HIV-1 responsible for the nanoscale distribution and dynamics of virus assembly

Project Summary
The detailed mechanisms of Human Immunodeficiency Virus Type 1 (HIV-1) assembly
constitute a significant gap in our understanding of the infection cycle of this devastating
pathogen. Specifically, the mechanisms by which the essential Envelope (Env) glycoprotein and
structural Gag molecule efficiently coalesce to form an infectious HIV-1 particle are poorly
understood, due to our inability to quantitatively measure the spatiotemporal dynamics of
individual molecules at the nanoscale within infected host cells. This proposal aims to delineate
the underpinnings of HIV-1 assembly on a single molecule basis and in a native cellular context.
To accomplish these aims, we propose to utilize superresolution microscopy to visualize and
quantify the stages of virus assembly in order to determine the role of key peptide motifs found
in HIV-1 Env and Gag. Our preliminary data and analytics demonstrate our ability to
quantitatively map the biogenesis of HIV-1 and strongly suggest that this approach will provide
unequivocal insight in the mechanisms of particle assembly. These discoveries will provide new
quantitative models to guide approaches aimed at thwarting HIV-1 assembly.

Public health relevance
Project Narrative Human Immunodeficiency Virus type 1 (HIV-1) remains as a pandemic scourge to our society, this warrants continued in-depth and mechanistic research focused on uncovering new routes for antiviral therapy and immune modulation. As such, this project proposal aims to uncover the molecular trajectories involved in HIV-1 particle assembly to understand the mechanisms used by the virus to limit exposure to the immune system and create new virus particles. Construction of detailed mechanistic models for HIV-1 assembly will proved a roadmap for future research aimed at inhibiting particle biogenesis or stimulating potent immune responses.